Systematic and scalable phenotyping of mouse mutants for neuropsychiatric disease genetics

PROJECT SUMMARY/ABSTRACT
In the past decade, significant progress has been made in identifying genetic variants associated with
neurodevelopmental and psychiatric disorders like autism, schizophrenia, and intellectual disability. However,
understanding how these genes affect brain function and contribute to disease remains a challenge due to the
diverse experimental approaches used. To address this, we have assembled the Washington University Scalable
Mouse Assay Center (WU-SMAC), an Assay and Data Generation Center (ADGC) for the SSPsyGene
consortium. We will comprehensively investigate the impact of prioritized mutations known to cause
neurodevelopmental and psychiatric disorders using over 100 mouse lines. Through a combination of behavioral
analysis, anatomical mapping, and molecular assessments, our project seeks to uncover the molecular and
spatial changes in the brain caused by these mutations and their subsequent effects on behavior. We will deeply
assess the phenotype of each mutant using high-content, machine-learning driven behavioral analysis,
automated home-cage monitoring of learning behavior and cognitive flexibility, and careful single nucleus &
spatial transcriptomics. We will coordinate data serving and distribution with the other ADGCs and Data
Resource and Administrative Coordination Center, and provide a unique mouse neuropsychiatric disease brain
bank for the entire consortium to enable the replication of findings from other ADGC's systems within the complex
milieu of a fully developed mammalian brain.

Public health relevance
NARRATIVE The Washington University Scalable Mouse Assay Center (WU-SMAC) for the SSPysGene consortium aims to comprehensively investigate the impact of genetic mutations linked to neurodevelopmental and psychiatric disorders, such as autism and schizophrenia, using a large collection of specialized mouse lines. By analyzing behavior, brain anatomy, and molecular changes, we seek to understand how these mutations influence brain function and behavior, shedding light on the underlying mechanisms of these complex disorders